Administrative Core

The Achilles Tendinopathy Center of Research Translation (AT-CORT) at the University of Pennsylvania will
foster fundamental discovery research to guide translation, as well as employ and develop translational
resources, models and technologies, to address the highly significant research and unmet clinical challenge of
Achilles tendinopathy. Despite the high frequency and increasing prevalence of tendinopathy to young and old
patients alike, the significant pain and disability, as well as the associated high cost to society, evaluation and
development of effective treatment modalities is hindered by the lack of fundamental guiding data on the
mechanobiology of tendon etiology and pathogenesis. At the University of Pennsylvania, we are uniquely
positioned with a critical mass of multidisciplinary scientists and clinicians with strong interest and expertise in
these and related areas. The Center’s efforts will span from the nucleus, to the cell, to the tissue, to in vivo
animal models and to living human subjects in a coordinated “back-and-forth” manner across scales to guide
innovative approaches to Achilles tendinopathy. The Center’s research will discover fundamental physiologic
processes to guide translation. It will also as serve as a test bed for defining the role, as well as the scientific
and translational rigor, of a repetitive use Achilles tendinopathy animal model through implementation of an
exciting series of in vivo longitudinal assays to be conducted in parallel in both animal and human subjects.
The Specific Aims of this Administrative Core are to: Aim 1: Provide leadership for Center components and
activities and advise the Center Director regarding current or potential future activities of the Center; Aim 2:
Manage, evaluate and monitor the Center components and activities; Aim 3: Communicate the Center’s
activities to the scientific, clinical, and lay communities; Aim 4: Administer the Pilot and Feasibility Grant
Program and its associated funding and reporting; and Aim 5: Implement an Enrichment Program. The Core
and Research Projects have been carefully developed in concert to bridge the fundamental and applied while
being highly interactive. With regular guidance from our Committee structure (External Advisory, Executive,
Communication, Enrichment), we will adapt our efforts to address our translational theme in the most efficient,
effective, and productive manner possible. Our Pilot and Feasibility Grant program will foster new and
innovative project directions consistent with our theme as well as support development of novel technologies to
bring to our projects and for translation of our efforts. Our approach will serve as a critical paradigm for other
tendon and indeed other musculoskeletal disorders and we will build on these efforts. A well organized and
well-structured Administrative Core is absolutely essential to accomplish the Aims of the Center’s highly
interdisciplinary and interactive Research Projects and Core, and to maximize research activity, efficiency,
productivity, communication, and ultimate impactful translation of our efforts to the scientific and lay
community.